Neurobiological Threat Reactivity as a Biomarker of Chronic Pain and Alcohol Use Disorder

PROJECT SUMMARY/ABSTRACT
Chronic pain and alcohol use disorder (AUD) frequently co-occur, leading to worse outcomes than either
condition alone. Although treatments for chronic pain and AUD exist, they often prove ineffective for individuals
suffering from both conditions. The unmet treatment needs in this group highlight the urgent necessity for
developing effective mechanism-driven interventions for chronic pain and AUD comorbidity. Prior research
suggests that a maladaptive response to uncertain threat may be a shared pathway linking chronic pain and
AUD. The unpredictability of a potentially painful impending threat can increase pain intensity and sensitivity
(hyperalgesia), elicit anticipatory anxiety, and activate the interoceptive brain circuit anchored in the anterior
insular cortex (AIC). The candidate previously showed that AIC circuit hyperreactivity to uncertain threat predicts
coping-motivated binge drinking in youth and characterizes individuals with AUD, and her preliminary data further
suggest that the AIC may also be a key region targeted by comorbid chronic pain and AUD. However, no study
has directly tested this hypothesis in individuals with chronic pain with and without AUD. To fill this knowledge
gap, the K99/R00 proposal will combine functional imaging probe of neural circuitry with longitudinal real-time
tracking of daily fluctuations in pain symptoms and alcohol use behaviors (consumption and craving) in adults
with and without chronic pain and AUD. The first aim will examine if individuals with both conditions show greater
AIC activation and connectivity than either condition alone compared with controls. The second aim will assess
how AIC circuit function correlates with the severity of chronic pain and AUD symptoms, hypothesizing that
higher symptom severity in both conditions will correspond to greater AIC activation and connectivity, with a
stronger effect for individuals with concurrent symptoms. The third aim will evaluate if AIC circuit function predicts
real-world chronic pain and AUD symptoms and, thus, is a useful treatment target. Completing this study will
support the candidate's transition to an independent investigator with a focused program of neuroimaging alcohol
and chronic pain research. Her career goals are to investigate coping strategies and mechanisms that develop
and maintain AUD in comorbid populations and to translate the knowledge gained from her research into more
effective prevention, intervention, and treatment strategies. To achieve these goals, the candidate will complete
formal coursework, and receive structured mentoring and supervised training in research and professional
development by experts in clinical phenomenology and neuroscience of chronic pain and AUD (Dr. Rajita Sinha,
primary mentor, and Dr. Declan Barry), machine learning and connectome-based-predictive modeling (Dr. Dustin
Scheinost), and through collaboration with a biostatistician with expertise in intensive real-time longitudinal data
collection and analysis (Dr. Eugenia Buta). The outstanding research environment and intellectual resources at
Yale University will provide the candidate with ample training in novel neuroimaging and analytical techniques
and guidance on data dissemination, networking, oral communication, and grant writing.

Public health relevance
PROJECT NARRATIVE People who suffer from chronic pain frequently self-medicate with alcohol and report greater incidence of alcohol use disorder than the general population, highlighting the need for treatments that will target co-occurring chronic pain and alcohol use disorder more effectively. This prospective study will examine how brain response to uncertainty measured in a laboratory brain imaging task relates to real-time assessments of daily pain, craving and drinking habits in individuals with and without chronic pain and alcohol use disorder. Results from this study will guide the development of behavioral and brain-based interventions, with the goal of managing intolerance of uncertainty in these individuals and improving overall treatment satisfaction, retention, and outcomes.